Shrinking the Size of the Tobacco Powerwall and Restricting the Number of Tobacco Products Displayed to Reduce Adolescent Tobacco Use

The tobacco industry spends over 90% of its multi-billion-dollar advertising and promotion budget at retail
point-of-sale (POS). The most prominent source of POS tobacco advertising comes from the tobacco power
wall, the large, expansive display of hundreds of different tobacco products typically located behind the cashier
in full view of consumers. Adolescents are frequent visitors to POS retail stores and as such are at significant
risk for having repeated exposures to the tobacco power wall. Such exposures can contribute to increases in
adolescent tobacco use risk and actual product use. As such, reducing the effect of the tobacco power wall on
adolescent tobacco use is a critical public health goal. Several options for curbing the potency of the tobacco
power wall have been advanced. The first option is a reduction in the amount of space that a tobacco power
wall may occupy. This action would reduce the size of the tobacco power wall by as much as half and as a
result, occupy less visible space behind the cashier counter. The second option is a reduction in the total
number of tobacco product units within brand that are displayed on the power wall. This action would permit
only one example of each brand to be displayed rather than several (e.g., rather than 10 boxes of Marlboro Reds
and 10 tins of Camel Frost Snus, there would be allowed only one package of each). The overall aim of this
research is to experimentally evaluate the extent to which reducing the size of the tobacco power wall and the
number of tobacco product units displayed influences tobacco use risk in adolescents. This experiment will
take place in the RAND StoreLab (RSL), a life-sized replica of a convenience store that we developed to
evaluate how altering aspects of tobacco promotion at POS influences tobacco use risk during simulated
shopping experiences. The study will use a between-subjects design, in which adolescents are randomly
assigned to shop in the RSL under one of three conditions: (1) Large power wall/ multiple product units
displayed; (2) Small power wall/multiple product units displayed; and (3) Small power wall/Single product
units displayed. We will consider the effect of these power wall alterations on risk of use of four classes of
tobacco products: cigarettes, electronic nicotine delivery devices, cigarillos, and smokeless tobacco. Tobacco
use risk will be indexed by: attention to the tobacco power wall, perceived tobacco use norms, perceived
availability of tobacco products, and tobacco use intentions. We hypothesize that the combination of these
regulatory options (i.e., a small tobacco power wall with single units of each product displayed) will most
effectively diminish tobacco use risk. We will also evaluate whether gender and/or tobacco use experience
moderate adolescents' reactions to the power wall regulatory options under investigation. The results of this
study have the potential to provide critical proof-of-concept information on how shrinking the tobacco power
wall could influence adolescent tobacco use risk and as a result, advance regulatory science aimed at helping
adolescents resist the powerful and tobacco-rich POS retail environment.

Public health relevance
The tobacco power wall, a large display of tobacco products typically located behind retail cashiers is a key part of the point-of-sale advertising mix and reducing its impact on adolescent tobacco use is a key goal for policy- makers. The research proposed in this application will conduct an experiment to test whether altering the size of the power wall and volume of products displayed on it influence adolescent tobacco use risk. The results of this research could have an impact on tobacco regulations issued by the Food and Drug Administration and/or regulations developed at the state and local levels.